Empowering gene discovery and accelerating clinical translation for diverse admixed populations

PROJECT SUMMARY/ABSTRACT
Gene discovery has revolutionized medical genetics, but gaps remain in the understanding of complex disorders
in minority populations, in particular “admixed” groups of mixed ancestry. Admixed populations are systematically
excluded from genomic studies due largely to the lack of analytic approaches that can account for their genomic
diversity. Admixed populations, including African American and Latinx individuals, make up more than a third of the
U.S. populace and have higher rates of some common complex disorders including cardiovascular disease, diabetes,
some cancers, and PTSD – disorders which rank amongst the top global contributors to years lived with disability.
Yet, these groups face severe disparities in health research and treatment due to being so sorely underrepresented
in genomics. To reap full and equitable benefits from existing and ongoing efforts including All of Us, there is an unmet
need for the development of tools permitting the study of complex traits in admixed peoples.
Dr. Atkinson proposes to address this pressing issue by developing a suite of innovative statistical methods,
software packages, and analytical resources that will make genomics more inclusive. In this 5-year R01 award, she
will: 1a) build a novel statistical method to allow for the integration of admixed individuals into rare variant association
studies; 1b) test this new method in a scalable cloud-based software implementation across phenotypes of varying
genetic architectures in the All of Us Research Program; and 1c) leverage the linkage disequilibrium in admixed
individuals to improve fine-mapping of top loci. We will also develop novel software tools to 2a) realistically simulate
diverse cohorts; which we will use to 2b) define best practice recommendations for multi-ancestry phasing, imputation,
and local ancestry inference; and 2c) assess the impact of common analytic strategies for diverse collections on gene
discovery outcomes. Finally, we will leverage admixture to 3a) extend our ancestry-informed frameworks to quantify
gene-gene interactions both locally and distally; and 3b) characterize trends in allelic effect size differences across
ancestry components with control over the environment. These efforts fill a major gap in existing resources and
remove barriers to the inclusion of underrepresented populations in medical genomics. This work is in direct line with
the strategic missions of the NIH/NHGRI to focus on inclusion and diversity, highlighting the crucial and timely nature
of the proposed project.

Public health relevance
PROJECT NARRATIVE There are major disparities in health research and treatment across ancestry groups. Specifically, “admixed” people – those whose DNA contains more than one ancestral component, including African American and Latinx individuals – are systemically excluded from studies due to the lack of available methods to appropriately handle their complex genomes. In this award, I propose to bridge this concerning gap in research space by developing novel computational and statistical methods to enable the study of complex phenotypes in admixed people, bettering our understanding of the genetic basis for clinically-meaningful traits in these diverse populations who have so far been understudied and underserved.